Development and characterization of human iPSC-derived neutrophil therapies against pathogenic Aspergilli

Project Summary
Over 300,000 new global cases of invasive pulmonary aspergillosis (IPA) are reported each year, with a mortality
rate as high as 90%. Therefore, the development of effective antifungal treatments is of high medical significance.
The current antifungal arsenal consists of 3 core classes of drugs: the azoles, echinocandins and polyenes.
However, increasing antifungal resistance within Aspergilli (azoles and echinocandins) and secondary
cytotoxicity (polyenes) limits the treatment options. Consequently, there is a need for the development of
alternative treatment strategies to control IPA progression. Granulocyte transfusion therapy (GTX) has been
pursued as an alternative treatment strategy for microbial infections, but the short lifespan of primary human
neutrophils and insufficient donor supply has limited the use of this approach. Induced human pluripotent stem
cell (iPSC) derived neutrophils (iNeutrophils) can be produced in large quantities independent of a donor, are
genetically malleable to permit engineering, and may serve as invaluable replacement to primary neutrophils in
GTX. However, the efficacy of iNeutrophils in controlling fungal growth is currently unknown. Our lab and others
have recently discovered that deletion of GATA1 in iPSCs, a transcription factor that is important in eosinophil
and basophil differentiation, results in a highly homogenous culture of mature iNeutrophils that are more
phenotypically similar to primary human neutrophils than previously characterized wild-type (WT) iNeutrophils.
This puts us in a unique position to use iNeutrophils in both therapeutic and mechanistic studies to assess their
interactions with human fungal pathogens. This proposal will therefore leverage WT and GATA1-/- iNeutrophils in
combination therapy with current antifungals to inhibit the growth of clinically relevant Aspergilli, and to generate
host pattern recognition receptor (PRR) knockouts to characterize mechanisms of fungal recognition that drive
neutrophil antifungal activity. This proposal seeks to achieve these goals by combining in vitro immunology
techniques with iPSC and fungal genetics. Aim 1 will assess the ability of iNeutrophils to independently inhibit
the growth of isolates from the two most common causative agents of IPA, A. fumigatus and A. flavus. These
findings will then be expanded to assess the ability of iNeutrophils to synergize with current antifungals in vitro
to further enhance fungal killing. Aim 2 will then begin to dissect how neutrophils sense pathogenic fungi in their
environment by characterizing the receptor network needed to recognize the immunogenic polysaccharide
ß(1,3)-glucan in the fungal cell wall. This will be achieved by generating iNeutrophil ß(1,3)-glucan receptor
knockouts and by utilizing Aspergillus mutants with altered ß(1,3)-glucan exposure levels. Together, this
approach will provide essential training opportunities in stem cell engineering, immunology techniques, and
filamentous fungal genetics, while also providing important insights into the iNeutrophil/neutrophil antifungal
response.

Public health relevance
Project Narrative Invasive pulmonary aspergillosis (IPA) is a significant problem among immunocompromised individuals and has an attributed mortality rate as high as 90% in certain areas of the world. This proposal seeks to alleviate this issue by assessing the killing efficacy of human stem cell-derived neutrophils (iNeutrophils) against the two most prevalent isolates of IPA, Aspergillus fumigatus and Aspergillus flavus. In doing so, this work will provide needed information on the potential of iNeutrophils as a novel antifungal therapeutic against IPA, while also elucidating mechanisms utilized by these cells to facilitate fungal clearance.